Impact of neurofibromin on ER-alpha and nuclear speck post-transcriptional gene regulation

F99CA284282
PI: Patrick Dischinger
Administrative Supplement for Fellowship Award – Childcare Costs
PROJECT SUMMARY / ABSTRACT
No change from original submission.

Public health relevance
F99CA284282 PI: Patrick Dischinger Administrative Supplement for Fellowship Award – Childcare Costs PROJECT NARRATIVE No change from original submission.